USER SOFTWARE DEVELOPMENT FOR BRAIN IMAGING

This subprojectconcerns the testing and incorporation of new algorithms for the analysis of autoradiograms into software packages made available to the scientific community. During this year we have released a new version of BRAIN and have distributed it to our users. Additionally 3 other applications have been developed and distributed. Two of these are plug-in filters for NIH Image, a widely used public domain software, and a stand-alone 3D application which allows users to reslice their volumetric dataset.